Tennessee Department of Agriculture - Animal Food Regulatory Program Standards Maintenance Project Proposal

Tennessee Department of Agriculture Animal Food Regulatory Program
Standards Maintenance Project Abstract
This project ensures animal feed safety in Tennessee by maintaining full compliance with the
Animal Food Regulatory Program Standards (AFRPS). Its primary goal is to protect public
health by preventing contaminated or adulterated animal feed from entering the human food
chain through meat, dairy, and egg products. Because unsafe feed can pose serious risks to
both livestock and human consumers, rigorous regulatory oversight is essential. The program
focuses on three main objectives to uphold AFRPS conformance. First, it sustains a
comprehensive inspection program, staffed by eight trained animal food inspectors and one
statewide supervisor. Second, it aims to meet SMG-8076 audit requirements by achieving at
least 50% annual inspection audit completion by Year 3. Third, it conducts risk-based
enforcement actions, including re-inspections, warning letters, stop sales, and permit
revocations. Close collaboration with the U.S. Food and Drug Administration (FDA) is central to
the program’s success. Through scheduled visits, technical assistance calls, and participation in
Association of American Feed Control Officials (AAFCO) meetings, the program ensures
consistent application of federal standards at the state level and remains aligned with evolving
national guidelines. The expected outcomes of the project include a sustained and strengthened
feed safety infrastructure in Tennessee, continued AFRPS compliance, improved inspection
audit performance, and enhanced enforcement capacity. Overall, the initiative protects both
animal and human health by preventing the distribution of unsafe feed, while supporting
Tennessee’s agricultural economy and reinforcing the integrity of the national animal food safety
network.

Public health relevance
Tennessee Department of Agriculture Animal Food Regulatory Program Standards Maintenance Project Narrative Since achieving full implementation and conformance to the Animal Food Regulatory Program Standards (AFRPS), the Tennessee Department of Agriculture (TDA) requests continued funding support through the AFRPS Maintenance Track to sustain and enhance TDA’s comprehensive animal feed regulatory program over the next three years. The requested funding of $225,000 annually will enable TDA's Consumer and Industry Services Division to maintain full conformance with current AFRPS requirements. This investment directly supports TDA’s mission to reduce hazards in firms that manufacture, process, pack, or hold animal food throughout Tennessee.